Learning Theory to Improve Obesity Treatments

DESCRIPTION (provided by applicant): There is an imperative need to alter current strategies for the prevention and management of obesity in children. Today's obesiogenic environment makes it impossible to reduce exposure to cues that trigger maladaptive eating behaviors. Thus, there is an urgent need to study basic behavioral mechanisms that can reduce the potency of these cues to trigger overeating. Given empirical advances in learning mechanisms related to Pavlovian conditioning, the time is ripe to utilize this knowledge to launch a program of research targeting novel treatments for obesity based on learning theory. Our preliminary data with overweight and obese 8-12 year old children suggests that a cue exposure treatment (CET-Food; based on Pavlovian extinction) can impact overeating. Although promising, basic knowledge is needed to improve CET-Food. The objective of this application is to conduct a series of formative experiments based on learning theory and other translation mechanisms to enhance and improve our current CET-Food to reduce overeating in children. We will evaluate pertinent outcomes related to overeating, including psychophysiological measurements of salivation and heart rate variability, self-reported cravings and a laboratory paradigm measuring overeating to determine the most effective factors to improve CET-Food. Based on the formative experiments, we will combine this knowledge and evaluate the acceptability and feasibility in a proof of concept intervention. Ultimately, we will conduct a pilot trial comparing family-based treatment for childhood obesity with CET-Food to family-based treatment alone. The overall goal of this application is to develop an optimized intervention that will be efficacios in reducing overeating in children, which can be used in randomized controlled trials. This research has the potential to improve the knowledge base for the management and control of obesity, and to inform a new wave of interventions for obesity. PUBLIC HEALTH RELEVANCE: The purpose of this application is to study extinction processes related to food cues, as a means of enhancing a cue exposure treatment (CET-Food) to improve obesity treatment for children. This project could result in identifying basic behaviora mechanisms which can lead to promising childhood obesity interventions.

Public health relevance
The purpose of this application is to study extinction processes related to food cues, as a means of enhancing a cue exposure treatment (CET-Food) to improve obesity treatment for children. This project could result in identifying basic behaviora mechanisms which can lead to promising childhood obesity interventions.